Fetal Neuroprotection by choline supplementation in heavy drinking pregnant women

PROJECT SUMMARY
Fetal alcohol spectrum disorders represent the most prevalent cause of preventable intellectual disability.
Prevalence in high-risk communities in the Western Cape region of South Africa may be as high as 20.9%.
Prenatal alcohol exposure (PAE) impacts the developing brain, resulting in cognitive deficits, growth restriction
and structural brain changes. Despite psychosocial interventions, heavy drinking during pregnancy continues
to be a major public health challenge in the Western Cape, U.S. and worldwide. In a recent preliminary study,
we showed that high dose maternal choline supplementation during pregnancy mitigates adverse effects of
PAE on infant growth and cognitive development, as well as neonatal brain structure. This proposal will add on
to a recently NIH-funded fully-powered, double-blind, randomized placebo-controlled trial in which 288 heavy
drinking Western Cape women will be given choline or placebo during pregnancy and infants will be assessed
through 12 months of age. We propose the addition of neonatal neuroimaging, including brain anatomical,
diffusion and metabolic spectral imaging, to examine neural mechanisms mediating the beneficial effects of
maternal choline supplementation on infant developmental outcomes. We hypothesize that choline
supplementation in heavy drinking pregnant women will reduce the adverse impact of PAE on the developing
fetal brain by normalizing anatomical development, connectivity, and brain energy metabolism.
Brain development is energy demanding and highly sensitive to nutritional reserves. Alcohol measurably
disrupts brain metabolites. Choline is a precursor to acetylcholine, a metabolite critical in healthy cell
development. Depletion of choline reserves coupled with alcohol-induced disruption adversely affects fetal
brain development. Our preliminary infant brain anatomical data show clear developmental effects of PAE and
the mitigating effects of maternal choline supplementation. We will combine the clinical and nutritional
information and infant cognitive test results from the clinical trial with the brain anatomical, connectivity and
metabolic measurements from the current study to augment our understanding of the mechanistic
underpinnings of the neuroprotective benefits of prenatal maternal choline supplementation on the developing
fetus in the setting of PAE.
We will develop capacity for acquiring region-specific neurometabolic information using magnetic
resonance spectroscopic imaging (MRSI) and deep learning to identify neonatal brain regions. This project
builds on the decades-long collaborations between Drs. Meintjes (University of Cape Town), S. and J.
Jacobson (Wayne State University School of Medicine), van der Kouwe (Massachusetts General Hospital) and
Carter (Columbia University). Drs. Choi and Lee, experts on measuring energy metabolism in prescribed brain
regions using MRSI, will serve as consultants on this study.

Public health relevance
PROJECT NARRATIVE Fetal alcohol spectrum disorders (FASD) represent the most widespread manifestation of preventable intellectual disability. Our preliminary data suggest that choline supplementation initiated early in pregnancy can ameliorate adverse growth retardation and some of the debilitating neurocognitive effects seen in FASD. In the current study, we will add neonatal brain anatomical, diffusion and metabolic imaging to our recently- funded, fully-powered clinical trial of choline supplementation in heavy drinking pregnant women in the Western Cape province of South Africa. This study will contribute to our understanding of the mechanistic underpinnings of the neuroprotective benefits of prenatal maternal choline supplementation to the developing fetus exposed prenatally to alcohol and has the potential to inform prenatal interventions and postnatal FASD remediation.